Dissecting the role of CD38 and metabolism in the heightened Treg potential of human neonatal naïve CD4+ T cells

Abstract
After birth, the developing human immune system encounters a multitude of new environmental antigens.
Balancing protection against infection with immune tolerance to limit detrimental and excessive tissue
inflammation is thus a critical function of the neonatal immune system, regulated in part by the capacity of naïve
CD4+ T cells to preferentially differentiate into regulatory T cells (Tregs). Immune cell metabolic state is closely
tied to function, and emerging research has revealed a distinct metabolic signature for neonatal versus adult
CD8+ T cells. Yet, how the metabolic states of early life T cells, particularly CD4+, relate to their distinct functional
capacities remains an understudied area of high biomedical relevance to pediatric health and the design of early
life therapeutics. I have shown that human neonatal naïve CD4+ T cells preferentially use glycolysis for ATP
generation and that this is closely tied to their heightened expression of CD38, a metabolic enzyme with many
cellular functions including NAD+ metabolism and intracellular calcium regulation. When treated with a
pharmacologic CD38 inhibitor, I observe that neonatal naïve CD4+ T cells demonstrate diminished capacity for
Treg differentiation despite preserved cell proliferation and activation. Through the proposed experiments, I aim
to test the hypothesis that the distinct metabolic state of human early life naïve CD4+ T cells, driven by their high
CD38 expression, facilitates their unique potential for Treg differentiation. To do so, I will define how the
metabolic state of neonatal naïve CD4+ T cells impacts their functional potential (Aim 1) and the mechanism by
which CD38 shapes the glycolytic dependency and tolerogenic potential of neonatal naïve CD4+ T cells (Aim 2).
This work will utilize cutting edge metabolic techniques and immunology assays, as well as pharmacological and
genetic approaches, to elucidate the connection between metabolism, CD38, and tolerance in early life.
Completion of these aims will shed light on fundamental mechanisms behind a critical time in immune
development and build a foundation for precision therapies that aim to augment or limit early life tolerance via
modulation of CD38 or other metabolic pathways.

Public health relevance
Project Narrative Early life is a critical window for human immune development and, especially, immune tolerance, which is supported by heightened differentiation of neonatal naïve CD4+ T cells into regulatory T cells (Tregs). Neonatal T cells have a unique metabolic state but how this relates to their distinct functional capacities remains an understudied area of high biomedical relevance to pediatric health and design of early life therapeutics. Here we investigate how the enriched Treg differentiation capacity of human neonatal naïve CD4+ T cells relates to their high glycolytic dependence and elevated expression of the metabolic enzyme CD38.